Modulating granulocytic myeloid-derived suppressor cell (G-MDSC) metabolic activity to promote Staphylococcus aureus biofilm clearance

Staphylococcus aureus (S. aureus) is a leading cause of biofilm-associated prosthetic joint infection (PJI)
characterized by antibiotic tolerance and evasion of immune-mediated clearance. Our laboratory has established
a critical role for granulocytic myeloid-derived suppressor cells (G-MDSCs), a pathologically activated neutrophil
precursor, in attenuating monocyte/macrophage (MФ) proinflammatory properties and neutrophil bactericidal
activity that leads to S. aureus biofilm persistence. The metabolic attributes of leukocytes are intimately linked
with their inflammatory properties, relationships encompassing the emerging field of immunometabolism. This
has been best described for MФs, where biases towards aerobic glycolysis or oxidative phosphorylation
(OxPhos) dictate pro- vs. anti-inflammatory activity, respectively. In contrast, little information is available
regarding the metabolic tendencies of G-MDSCs during infection and our preliminary studies are the first to
demonstrate that G-MDSCs exhibit a glycolytic bias following S. aureus biofilm exposure in vitro and in vivo.
Importantly, blocking glycolysis in G-MDSCs attenuated their suppressive activity resulting in decreased biofilm
burden in vivo. This provides proof-of-concept that targeting G-MDSC metabolism is a tractable and novel
approach to promote biofilm clearance. Recent studies have revealed that mitochondria can directly traffic
between cells in vitro and in vivo via tunneling nanotubes (TNTs), where mitochondrial transfer in recipient cells
promotes their OxPhos activity. However, most of these reports examined TNT-mediated mitochondrial transfer
between mesenchymal stem cells and endothelial cells or cardiomyocytes, whereas this mechanism of
intercellular metabolic rewiring has not been explored in the context of MФ-G-MDSC crosstalk. These studies
will leverage MФs as a source of mitochondria for reprogramming G-MDSC metabolism, which originated from
our prior work showing that MФ adoptive transfer reduced S. aureus biofilm burden in vivo. Indeed, our
preliminary data support this innovative concept, where MФs transferred their mitochondria to G-MDSCs in a
cell contact-dependent manner, which skewed G-MDSC metabolism towards OxPhos. This R21 revision will
investigate the hypothesis that increasing mitochondrial abundance in G-MDSCs will result in metabolic
reprogramming from glycolysis to an OxPhos bias coincident with diminished immune suppressive activity,
resulting in improved biofilm clearance. Understanding how mitochondrial transfer from MФs can reprogram G-
MDSC metabolism will be examined leveraging natural transfer and exogenous mitochondrial treatment
paradigms in the following Specific Aims. 1) Identify the functional implications of mitochondrial transfer on G-
MDSC anti-inflammatory activity and 2) Determine whether augmenting G-MDSC mitochondrial activity improves
S. aureus clearance during PJI. These studies will inform our long-term goal of targeting critical metabolic nodes
to reprogram aberrant leukocyte anti-inflammatory responses to eradicate biofilm together with antibiotics.

Public health relevance
Many medical device infections are caused by Staphylococcus aureus (S. aureus), which are debilitating due to their chronicity and antibiotic tolerance. We will explore the possibility that rewiring the metabolism of granulocytic myeloid-derived suppressor cells, an immune population that is key in preventing biofilm clearance, will inhibit their immune suppressive effects and decrease S. aureus burden. A better understanding of how metabolism controls immune cell function will guide the development of future strategies for the treatment of S. aureus biofilm infections.